Perfluorooctanoic acid: a potential environmental modulator of susceptibility to gestational diabetes mellitus

PROJECT SUMMARY
Gestational diabetes mellitus (GDM) is a form of diabetes that manifests during pregnancy and is
characterized by hyperglycemia and glucose intolerance due to pregnancy-driven insulin resistance and
inadequate pancreatic beta cell adaptation. GDM has a worldwide prevalence of 1.1-31.5 % and is influenced
by race, ethnicity, age, body composition, and screening and diagnostic criteria. The rate of GDM in the US
has increased by 30% from 2016 to 2020 and is expected to continue to increase in subsequent years.
Women with GDM have an increased risk for pregnancy complications and adverse health conditions following
pregnancy, while their fetuses face risks such as premature birth and developing metabolic disease later in life.
Published studies have demonstrated that pancreatic beta cell proliferation is critical for maintaining healthy
maternal glucose levels during pregnancy. One mechanism regulating beta cell proliferation is serotonin-
dependent activation of the G1 cyclins for the cell cycle by the binding of serotonin to the HTR2B receptor. This
mechanism is driven by pregnancy-induced activation of the tryptophan hydroxylase 1 gene (Tph1) and local
islet serotonin production, a vitamin B6-dependent process. Previous work from our lab has shown that
nutritional and genetic factors influencing maternal vitamin B6 levels can alter islet serotonin levels and beta
cell proliferation, inducing hyperglycemia and glucose intolerance in pregnant mice deficient in vitamin B6. The
proposed research aims to identify environmental and genetic modulators of maternal vitamin B6 to help
identify risk factors associated with the development of GDM. Specifically, the proposed studies will investigate
the effects of perfluorooctanoic acid (PFOA) on maternal pancreatic beta cell proliferation. PFOA is a synthetic
and ubiquitous endocrine disrupting chemical (EDC) that has been detected in blood of humans and wildlife,
soil, water, and household products across the globe. Preliminary findings from our lab indicate that gestational
exposure to PFOA reduces levels of islet vitamin B6 and serotonin. The proposed studies will test the
overarching hypothesis that PFOA exposure at an environmentally relevant dose alters glucose
homeostasis regulation and GDM susceptibility in pregnant mice through mechanisms that are
dependent on serotonin-driven beta cell proliferation. Elucidating the mechanisms by which gene-
environment interactions alter maternal vitamin B6 levels is pertinent to understanding the disparate risks for
GDM among individuals and populations. These studies will provide new insights that will benefit maternal and
child health outcomes.

Public health relevance
PROJECT NARRATIVE Gestational diabetes mellitus (GDM) is one of the most common pregnancy complications, and is influenced by a multitude of risk factors including race, ethnicity, age, body composition, environmental exposures, and genetic predisposition. The proposed research explores a novel mechanism by which perfluorooctanoic acid (PFOA), a ubiquitous and persistent endocrine-disrupting chemical (EDC), modulates maternal vitamin B6 and susceptibility to GDM, utilizing an environmentally and human-relevant PFOA dose. These studies can reveal areas for clinical intervention to help prevent or reduce GDM, ultimately improving the health of pregnant women and their offspring.